Team Functioning in School Mental Health Teams Implementing CBT

PROJECT SUMMARY/ABSTRACT Children obtain more mental health services through schools than through any other public system or agency. In Philadelphia, similar to many other urban school districts, school-based mental health care often is provided by school therapeutic support (STS) teams. The Philadelphia STS model, a common school-based mental health model, shares features with community mental health team models. In an effort to improve STS services in Philadelphia, the Philadelphia Department of Behavioral Health has contracted with the Beck Initiative to provide lead clinicians with extensive training and consultation in the broad application of cognitive- behavioral therapy (CBT), including for disruptive behavior disorders. STS clinicians may struggle to implement CBT due in part to challenges obtaining support from other members of the STS team. Current training models focus on EBP training for clinicians and neglect the functioning of the teams they operate within. This overall lack of attention to the broader team system may be contributing to failure to use EBPs in schools, as training alone has been shown to be insufficient. Participants for the proposed study will be drawn from STS teams in the Philadelphia community mental health network. In collaboration with stakeholders, Team Strategies and Tools to Enhance Performance and Patient Safety (TeamSTEPPS), an evidence-based approach for improving team functioning in health care settings, will be adapted for use with school mental health teams. Second, the adapted TeamSTEPPS will be pilot tested. Feasibility and acceptability of the adapted TeamSTEPPS approach, as well as the impact of the approach on team skills and behavior, will be assessed. Teams of STS paraprofessionals and clinicians in two schools participating in an ongoing implementation of CBT in Philadelphia will receive the adapted TeamSTEPPS approach, to be compared with two schools in which the lead clinicians receive CBT training as usual without TeamSTEPPS. Mixed methods will be used to examine contextual predictors of implementation, such as implementation climate, organizational readiness for change and attitudes toward teamwork in STS teams and their relationship to feasibility and acceptability. This project extends our understanding of strategies to improve EBP implementation among school-based mental health care teams and has broader implications for mental health treatment teams in other settings such as community mental health. The proposed research will coincide with advanced training opportunities and mentorship to develop expertise in implementation science.

Public health relevance
PROJECT NARRATIVE The present study will develop and test an implementation strategy to improve team functioning for mental health teams working in schools, with the ultimate goal of providing better quality evidence-based services to youth. This project extends our understanding of strategies to improve evidence-based practice implementation among school-based mental health care teams and has broader implications for mental health treatment teams in other settings (e.g., community mental health). __SpecificAimsTextDelimiter__ SPECIFIC AIMS This application requests funds to develop and test an implementation strategy to improve team functioning among mental health teams working in schools with the ultimate goal of providing better quality evidence- based services to youth. Children obtain more mental health services through schools than through any other public system or agency [1]. In Philadelphia, similar to many other urban school districts, school-based mental health care often is provided by school therapeutic support (STS) teams. These teams, which comprise com- munity mental health clinicians contracted to work in schools, typically consist of 1-2 masters-level clinicians supported by paraprofessional behavioral health workers (i.e., persons trained to assist independent clinicians but do not themselves have professional licensure). The Philadelphia STS model, a common school-based mental health model [2], shares features with community mental health team models [3]. In an effort to improve STS services in Philadelphia, the Philadelphia Department of Behavioral Health has contracted with the Beck Initiative to provide lead clinicians with extensive training and consultation in the broad application of cognitive- behavioral therapy (CBT), including for disruptive behavior disorders [4]. As a trainer and consultant with the Beck Initiative, I have seen lead clinicians struggle to implement CBT. This may be due in part to challenges obtaining support from other members of the STS team in implementing CBT strategies. Current implementa- tion strategies focus on EBP training for clinicians and neglect the functioning of the teams and context within which they operate. This overall lack of attention to the broader team system may contribute to difficulty with implementation of EBPs in schools [5]. The Consolidated Framework for Implementation Research (CFIR; [6]) provides a guiding heuristic frame- work for the present project. STS teams represent an understudied inner setting: the structural, cultural, and political contexts through which implementation proceeds. Inner setting constructs such as communication and implementation climate (e.g., learning climate, leadership engagement) have been insufficiently explored, con- tributing to the importance of the proposed study. The growing body of literature on team science has been applied successfully to medical teams and presents an opportunity to be applied to mental health teams [7, 8]. One particular evidence-based approach, Team Strategies and Tools to Enhance Performance and Patient Safety (TeamSTEPPS"[9, 10]), has been widely disseminated in health care settings and provides a promis- ing strategy for addressing communication and climate in STS teams. TeamSTEPPS" is designed to build competencies in the areas of leadership, situation monitoring, mutual support, and communication [8] and has been associated with improvements in teamwork and communication [11, 12] as well as patient outcomes, such as decreased seclusion in inpatient mental health [13]. This approach has yet to be extended as an im- plementation strategy in school or community mental health care teams. STS teams in Philadelphia, in many of which lead clinicians already have received extensive training in im- plementing CBT for disruptive behaviors in the school setting, provide an ideal context to explore the applica- tion of TeamSTEPPS" as an implementation strategy. I propose to examine the feasibility and acceptability of an adapted version of TeamSTEPPS", and observe its effects on team skills and behaviors. The specific aims of the proposed study are as follows: Aim 1. In collaboration with stakeholders, I will adapt TeamSTEPPS" for use with school mental health teams. Stakeholder input will be obtained via a community advisory board. Aim 2. To pilot the adapted TeamSTEPPS" approach. I will examine feasibility and acceptability of the adapted TeamSTEPPS" approach as well as the impact of the approach on team skills and behavior. Teams of STS paraprofessionals and clinicians in two schools participating in an ongoing implementation of CBT in Philadelphia will receive the adapted TeamSTEPPS" approach, and be compared with two schools in which the lead clinicians receive CBT training as usual without TeamSTEPPS". Aim 3. To examine contextual predictors of implementation including implementation climate, organizational readiness for change, and attitudes toward teamwork in STS teams and their association with perceptions of feasibility and acceptability of the adapted TeamSTEPPS". Participants for the proposed study will be drawn from STS teams in the Philadelphia community mental health network. Quantitative assessments of team skills and behaviors and contextual predictors of implemen- tation will be combined with qualitative assessments of feasibility and acceptability to address these aims. This project extends our understanding of strategies to improve EBP implementation among school-based mental health care teams and has broader implications for teams in other community mental health settings. The pro- posed research will coincide with advanced training opportunities and mentorship to develop my expertise as an implementation scientist.